Redesigning Preventive Care Recommendations for Diverse Populations of Veterans

Background: Conventional recommendations in national prevention guidelines often fail to address
differences in outcome risk and life expectancy across the target population. By ignoring such differences,
conventional recommendations can inadvertently lead to substantial underuse (by excluding Veterans with
potentially high net benefit who do not meet a conventional cutoff) and overuse (by including Veterans for
whom net benefit would be limited). Further, minoritized patients who could most benefit from prevention are
often disproportionately excluded by conventional recommendations, exacerbating racial disparities. The long-
term goal of the proposed research is to support optimal preventive care decisions for all Veterans. The overall
objective of this proposal is to study an alternative guideline approach (“tailored” recommendations based on
multivariable prediction) that can better support individualized prevention efforts. A second goal is to study the
extent to which optimizing decisions for individuals can broaden the public health impact of preventive care
programs within VA. We use lung cancer screening, statin use, and blood pressure treatment as case studies
as they are ideal models for studying the key issues.
Significance: This work is significant because current knowledge gaps in guideline development, which we
address in this proposal, inhibit progress toward more nuanced preventive care recommendations that often
better identify high-benefit patients and enable more Veteran-centered care.
Innovation and Impact: The proposed research is innovative because it will advance a different paradigm for
developing preventive care guidelines both within and outside VA, which will open new horizons for optimizing
the delivery of cancer screening, cardiovascular prevention, and other prevention. The rationale underlying the
proposed work is that its successful completion would enable guideline-level assessment of when tailored
recommendations would be highly advantageous, to promote more effective and personalized care and
reduce racial disparities.
Specific Aims: Aim 1: Estimate “individualized” net benefit for lung cancer screening, statin use, and blood
pressure treatment. Aim 2: Estimate the comparative effects of conventional recommendations vs. tailored
recommendations. Aim 3: Identify best practices for examining tailored recommendations in future guidelines.
Methods: Under Aim 1, we will adapt existing microsimulation models for each preventive service to estimate
the distribution of predicted (“individualized”) net benefit across the target Veteran population. This will inform
the development of tailored recommendations under the guidance of the Aim 3 Expert Panel. Then, in Aim 2,
we will use Aim 1 microsimulation evidence to examine the pros and cons of conventional vs. tailored
approaches, again with close input from the Expert Panel. For Aim 3a, an Expert Advisory Panel of guideline
experts will engage in a longitudinal process to identify best practices for conducting and presenting these
microsimulation analyses in the development of future preventive care guidelines. In Aim 3b, interviews with
guideline stakeholders will assess the potential for this microsimulation evidence to influence how future
recommendations are established.
Next steps/Implementation: The final product will be new guideline-level methods to support the adoption of
tailored recommendations in national guidelines, when doing so would improve care (particularly among
minority groups) and enable more Veteran-centered shared decision making. We will disseminate our work
through professional channels, including through multiple research publications and presentations. Our strong
engagement with VA guideline partners and experts from influential national guideline groups will facilitate
wide dissemination of these methods to guideline groups. Our separate line of research to study and
implement clinical decision support tools will support the downstream implementation of the proposed work.

Public health relevance
The proposed research is relevant to Veteran health because it focuses on improving how national prevention guidelines, which strongly influence preventive care practice in the VA, determine who is eligible for evidence- based prevention. Recent research shows that, for a diverse population, using multivariable prediction to estimate an intervention’s “individualized” net benefit, and to develop what are called tailored recommendations, is a promising alternative to conventional guideline recommendations. Once novel guideline-development methods are developed in this proposal (i.e., best practices for developing and examining tailored recommendations in guidelines), there is the potential for a significant advance toward more nuanced prevention guidelines that, in many cases, could avert more deaths, improve life-year gains, reduce racial disparities, and support more patient-centered shared decision making. Thus, the proposed research supports VA’s mission to advance scientific knowledge to help Veterans live longer, healthier lives.